Ion Channels and Membrane Receptors in Pulmonary Arterial Hypertension

PROJECT SUMMARY/ABSTRACT
Pulmonary arterial hypertension (PAH) is a fatal and progressive disease with unknown etiology and poor
survival rate. Pulmonary vasoconstriction, vascular remodeling and occlusive intimal lesion are the major causes
for the elevated pulmonary vascular resistance (PVR) in PAH. A rise in cytosolic Ca2+ concentration ([Ca2+]cyt) is
a trigger for pulmonary arterial smooth muscle cell (PASMC) contraction (and vasoconstriction) and a stimulus
for PASMC proliferation/migration (and vascular remodeling). In addition, the contractile-to-proliferative
phenotypic transition (CPPT) in PASMC and endothelial-to-mesenchymal transition (EndMT) in pulmonary
arterial endothelial cells (PAEC) are implicated in the development of pulmonary vascular remodeling and
obliterative intimal lesion in PAH. We recently found that Piezo1, a mechanosensitive cation channel, and
CALHM1 (calcium homeostasis modulator 1), a voltage-gated cation and ATP channel, are upregulated during
CPPT and involved in vascular remodeling in PAH/PH. Upregulated Piezo1 in PAEC enhances EndMT via the
Ca2+/AKT/mTOR-Jagged1 (Jag-1) signaling axis and is involved in the development of occlusive vascular lesion
and concentric vascular remodeling in animals with experimental pulmonary hypertension (PH). In addition, we
identified GPR91 (a succinate-activated GPCR) and GPR68 (a mechanosensitive GPCR) that are involved in
the development of pulmonary vascular remodeling in PAH/PH. The central hypothesis is that ionic (channel)
remodeling is required for phenotypic transition of PASMC/PAEC. Upregulated channels (Piezo1/CALHM1) and
receptors (GPR68/91) are required for causing pathogenic overgrowth of PASMC/EC through activation of Ca2+-
sensitive signaling and compartmentation of AKT/mTORC1 signaling, and contribute to vascular remodeling and
occlusive intimal lesion in PAH. The overall goals of this study are to examine: 1) gene expression profile
associated with the phenotypic transition of PASMC (CPPT) and PAEC (EndMT), 2) cellular and molecular
mechanisms involved in CPPT in human PASMC, 3) whether Piezo1 and mechanosensitive Ca2+ signaling
contribute to inducing and regulating EndMT in PAEC and whether endothelial Piezo1 is involved in the
development of PH, 4) how compartmentalized AKT/mTORC1 signaling and spatiotemporal Ca2+ signaling are
involved in EndMT in PAEC and enhanced PAEC proliferation in PAH/PH, 5) whether viroporins (e.g., SARS-
CoV-2 E protein) form non-selective cation channels to promote Ca2+ influx and stimulate PASMC/EC
proliferation, and 6) whether and how Ca2+ influx through upregulated cation channels and activation of selected
receptors contribute to regulation of inflammasome in PASMC/EC. The importance of this research program is
in its integrative design and translational potential in which we will define the pathogenic mechanism, identify
new therapeutic targets, and develop novel therapies for PAH/PH based on our studies on mechanosensitive
channels/receptors and Ca2+ signaling in PASMC and PAEC.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary arterial hypertension (IPAH) is a rare and fatal disease that predominantly affects women. Abnormalities in pulmonary arteries, the blood vessels in the lungs, have been shown to associate with the elevated blood pressure in the lungs. This study is designed to determine the role of membrane receptors and ion channels, proteins on cell surface membrane that mediate cell growth and mobility in the cellular processes that lead to the high blood pressure in the lungs in patients with this devastating disease, and to reveal potential novel targets for therapeutic approaches to treat IPAH.